Conference Grant (R-13) Covering Three Years of Cochlear Implant Clinical Research Symposia to be held in 2021, 2022 and 2023

Project Summary/Abstract
This application seeks partial funding for three years of cochlear implant (CI) clinical research
conferences to be convened by the American Cochlear Implant Alliance in April 2021 (Dallas), May 2022
(Washington, DC) and Spring 2023 West Coast TBD. The CI meetings provide a unique opportunity for
CI clinicians from across the continuum of care (i.e., ENTs, audiologists, speech pathologists,
psychologists), educators, and scientists to learn together. Virtual participation will be offered.
In the first year of the grant, we will convene CI2021 Cochlear Implantation: It Takes a Village. The
program for CI2021 will focus on clinical research relative to specific aspects of the cochlear implant
process for children and adults including: team approach to managing the range of CI patients including
bilingual patients and families, special needs populations and others receiving cochlear implants under
expanded indications; role of therapy, education and family engagement for pediatric and adult patients;
hearing preservation; telehealth; cognition and effect on outcomes; vestibular assessment; advances in
CI and surgical techniques; and alternative methods of managing hearing loss. Increasingly the need for
a team that includes individuals who are not “traditional” CI clinicians is recognized in light of the
expanded indications that are driving growth in individuals now considered good CI candidates.
Students may apply for waived registration and financial support and may enter a student poster
competition with interviews conducted by an interdisciplinary committee. A post-conference afternoon
seminar for deaf and hard of hearing adults, parents of children with hearing loss, and other family
members will be held to share translational research content for a non-clinician audience.
We will explore the best practice models to support an expansion in CI indications and the likely
increased volume of patients eligible for care. Our three specific aims for the conference are to: (1)
explore comparative outcomes of CI recipients implanted under expanded indications including special
needs populations, bilingual patients, and device variables that contribute to performance; (2) evaluate
clinical practice models to determine if they are able to effectively support a growing patient population
and suggest future changes in clinical practice; (3) determine research needed to better advise patients
and address current variability in outcomes among the CI recipient population.

Public health relevance
Project Narrative With expansion of cochlear implant candidacy, the CI patient population now includes those who previously would not have been considered good candidates: children and adults from bilingual families, those with special needs, very young children (starting at 9 months), and people of all ages with single-sided deafness and more residual hearing. Our challenge now becomes how can we best treat this new patient pool to provide people of all ages and from diverse demographic backgrounds with appropriate treatment while still maintaining a sustainable practice model.